Ambystoma Genetic Stock Center

PROJECT SUMMARY
The Ambystoma Genetic Stock Center (AGSC) is a P40 Research Resource that distributes
laboratory axolotls (Ambystoma mexicanum) to researchers and educators nationally and
internationally. The AGSC is currently working on a project to develop a reproducible protocol
for cryopreserving axolotl sperm, which is needed to efficiently manage axolotl stocks within the
AGSC and the broader axolotl community. Early results from this project found that axolotl
spermatids are viable for only a short time after they are packaged into structures called
spermatophores. This presents a challenge to develop a sperm cryopreservation protocol
because there is a narrow window of time within which spermatophores can be harvested to
obtain viable sperm. Additionally, spermatophores were found to be laid by males at various
times of the day, more often at night and not during the workday. Temporal parameters for
collecting spermatophores with viable sperm have not been defined because the mating
process has never been rigorously monitored to know when spermatophores are deposited.
Until these parameters are defined, it will not be possible to collect large numbers of viable
spermatophores from which to develop and optimize methods for cryopreservation. There is
critical need to develop a standard protocol for collecting spermatophores with viable sperm.
There is also critical need to optimize and gain capacity for sperm freezing and thawing at the
AGSC, and to integrate in vitro fertilization into the workflow. To address these needs, the
AGSC will hire a full-time employee with previous experience in cryopreservation and axolotl
biology. The new employee will work with undergraduate student workers to monitor axolotl
courtship during the day and night for the purpose of recording behavioral data and collecting
spermatophores. Spermatophores will be frozen and thawed using reagents and conditions
recommended by the Aquatic Germplasm and Genetic Resources Center (AGGRC) at the
Louisiana State University Agricultural Center and experiments will be performed to assay
sperm viability and in vitro fertilization success. Protocols arising from the proposed work will be
made publicly available. This administrative supplement will accelerate progress in developing
an axolotl sperm cryopreservation protocol and building AGSC capacity to manage germplasm
for the axolotl community.
.

Public health relevance
PROJECT NARRATIVE Living stock resources are needed for the Mexican axolotl so that investigators can develop research models and translate biological information that is relevant to human health and disease. The Mexican axolotl is a primary vertebrate model for organ regeneration, tissue repair, and post-embryonic development.